MOLECULAR BASIS OF INHERITED IMMUNODEFICIENCY DISORDERS

The purpose of this study is to determine the molecular basis of inherited forms of immunodeficiency. For patients who have defects in known genes, the specific mutation in the patient's DNA will be defined.